Reimbursement request for attending the Meeting of the Jointly Sponsored Institutional Predoctoral Training in the Neurosciences T32 Program Directors in Baltimore, MD on 2/19/19

This request seeks reimbursement for attending the Meeting of the Jointly Sponsored Institutional Predoctoral Training in the Neurosciences T32 Program Directors in Baltimore, MD on 2/19/19. I am the University of Washington JSPTPN T32 PD. The presentations and informal discussions in which I participated at the meeting will improve quantitative training in our Neuroscience Graduate Program throughout students’ time in graduate school, beyond required coursework and electives in the first few years.

Public health relevance
This request seeks reimbursement for attending the Meeting of the Jointly Sponsored Institutional Predoctoral Training in the Neurosciences T32 Program Directors in Baltimore, MD on 2/19/19. I am the University of Washington JSPTPN T32 PD. The presentations and informal discussions in which I participated at the meeting will improve quantitative training in our Neuroscience Graduate Program throughout students’ time in graduate school, beyond required coursework and electives in the first few years. Reimbursement is requested for the following: Airfare from Seattle, WA to Baltimore, MD ($163.30) Local transportation from and to BWI ($58.29) Airfare from Baltimore, MD to Seattle, WA ($237.00) 2-day parking at the SEATAC airport ($60) Food and beverages the day of the meeting, provided by U Maryland ($41) One night at the recommended hotel ($114.35) These expenses total $673.94, below the $700 maximum for attending this meeting (see NOT-NS- 16-025). Receipts for all of these expenses are attached.